Interdisciplinary Research Training in Health and Aging

Project Summary/Abstract
The proposed program, “Interdisciplinary Research Training on Public Health and Aging” (IRTHA) seeks a five-
year continuation of the current award, which was originally funded in 2008 and renewed most recently in May
2020. The IRTHA program provides interdisciplinary research training in the structural, social, and behavioral
determinants of later-life health outcomes, and their relationships with the biological mechanisms associated
with aging. This training is achieved through a four-part training model: (1) didactic coursework that provides an
interdisciplinary foundation in conceptual models, study designs, and analytic approaches in public health and
aging research; (2) engagement in mentored research projects, supported by a network of committed mentors
from a range of disciplines, (3) training in the use of population-based aging datasets, including activities that
connect trainees with other early-career aging researchers supported by complementary programs and centers
at the University of Michigan; and (4) professional development in the collaboration, communication, and
leadership skills essential for productive research careers in the field of aging. The IRTHA training program has
its disciplinary foundation in social epidemiology, while emphasizing collaboration with other disciplinary
perspectives, including other public health sciences, social sciences, biological sciences, and medical sciences.
IRTHA is housed within the Center for Social Epidemiology and Population Health (CSEPH) at the University of
Michigan School of Public Health and is supported by a network of 20 Faculty Mentors from diverse fields with
well-established research and training records. IRTHA trainees further benefit from connections with all six NIA-
funded P30 Aging Centers at the University of Michigan. IRTHA has a long-standing record of successfully
recruiting outstanding trainees who have made strong professional progress. To-date, a total of 24 predoctoral
trainees have participated in IRTHA, 4 of whom are currently enrolled in the program, 2 of whom have completed
the program and are still in doctoral training, and 18 of whom have graduated from their doctoral programs. Of
these 18 graduates, 17 (94%) have pursued research careers, with the majority in a tenure-track academic
position (59%). The IRTHA program has regularly been oversubscribed with strong applicants and has a robust
eligible applicant pool. In this renewal, we thus seek to increase from 8 to 12 total predoctoral trainees over the
five-year project period. Trainees will be enrolled in the program for 2 years each, with 3 (increased from 2) new
trainees being recruited in each of the first 4 years of the program. Graduates of the IRTHA program are and will
be poised to lead productive research careers that push forward the state of science on aging and pursue
answers to some of the most pressing public health challenges facing our rapidly aging population.

Public health relevance
Project Narrative This program provides interdisciplinary research training in the structural, social, and behavioral determinants of later-life health outcomes, and their relationships with the biological mechanisms associated with aging. The program leverages a diverse network of faculty advisors and a strong institutional research environment in public health and aging at the University of Michigan. Through didactic coursework, engagement in mentored research projects, training in the use of population- based aging datasets, and professional development activities, trainees will be prepared to address the public health challenges posed by our rapidly aging population.